Laboratory for Early Psychosis Research (LEAP)

1. Abstract
We propose to create a NIMH P50 ALACRITY Center that develops the collaborations, data systems, and
methods necessary to form a state-wide Laboratory for Early Psychosis Research, aka the LEAP Center.
While recent trial evidence suggests great promise for coordinated specialty care (CSC) for patients with first
episode psychosis (FEP), there remain several gaps in the knowledge base for the care of psychosis in
general. Now is an ideal time to address these gaps because of recent policy changes enhancing FEP care
financing, practice changes in the field, and methods developed outside of mental health. To create this
Center, we will start with interdisciplinary collaborations between CSC clinics in Massachusetts, policy
makers/regulators, and stakeholders, and include FEP experts from across the country plus scientific experts
from outside of mental health, e.g., in data science, machine learning, epidemiology, and health policy. We
also will leverage recent Massachusetts efforts to mandate, standardized, and support data collection on FEP
care structures, delivery, and outcomes from all FEP clinics within the state. We also will apply and develop
modern methods for clinical prediction and comparative effectiveness research (CER), e.g., machine learning
and g-methods, for FEP research. Accordingly, we have three overall Center aims: 1) Collaborations; 2) Data
systems; and 3) Prediction and CER methods. The Center will start with three foundational and complementary
projects: 1) Using the state All Payer Claims Database (APCD), Project 1 will apply a population-level
approach to examine which patients receive care in FEP clinics offering CSC versus elsewhere, as the number
of clinics increases, then estimate the treatment effect on unfavorable clinical event rates such as
hospitalizations; 2) Project 2 will review the data collected by the state from all of the FEP clinics, assess and
improve data collection quality, validate measures, and integrate perspectives; and 3) Project 3 will define
clusters of patients using longitudinal outcome data (i.e., begin to unpack the amount of clinical heterogeneity),
predict the cluster type for individual patients, and examine the impact of CSC treatment accounting for this
clinical heterogeneity. The Administrative Core and Methods Core (Prediction and CER) bind these projects
together. The Center will include a group of Scientific Advisors from across North America, Center Faculty from
diverse scientific disciplines, including those that historically have had little exposure in mental health research,
and Stakeholders, including policy makers, organizational decision makers, and patient and family advocates.
All three groups will be deeply involved in the Center from design to dissemination. The overall goal is to create
a state-wide learning health system for early psychosis. This effort to create the protocols and apply the
methods necessary to convert large amounts of data into useful clinical and policy knowledge will inform other
national efforts, e.g., NIMH’s EPINET.

Public health relevance
Project Narrative Psychotic disorders such as schizophrenia are common illnesses with serious, negative effects on patients and families; fortunately, recent studies suggest that early coordinated treatment might help mitigate some of these adverse effects. There remain many questions, however, about the disease course and treatment options, including what treatments will work best for which patients. This Center will be dedicated to addressing these questions by bringing together leading clinicians and scientists, and creating the systems needed to conduct studies to provide guidance to patients, families, and clinicians in the future.